AI-LIVER: Advancing Liver Transplantation through AI-Driven Outcome Prognostication and Normothermic Perfusion Data Exchange

Liver transplantation stands as the sole curative remedy for individuals grappling with end-stage
liver disease. The scarcity of donor livers poses a formidable obstacle, compounded by the
substantial number of discarded organs due to viability concerns. The advent of Normothermic
Machine Perfusion (NMP) during the past few years has opened a new era by employing machine
perfusion to enhance liver graft viability. Normothermic perfusion has specifically emerged as a
revolutionary technique, involving the assessment and reconditioning of donor livers at normal
body temperature (35-37°C). This process extends liver viability and augments transplant
success. While normothermic perfusion holds immense promise, it is currently hindered by the
lack of comprehensive data and standardized protocols. We propose to establish an international
cohort of NMP cases using a tailored digital data collection, storage, and sharing system under
the PUMP consortium, the PUMP platform, and leverage machine learning and artificial
intelligence to standardize protocols, identify key markers of liver viability, and predict post-
operative outcomes. The project has two main objectives: to establish a international cohort of
NMP cases through the usage of the PUMP platform (Aim 1) and developing a machine-learning
engine to predict post-operative outcomes using the registry data (Aim 2). To achieve this, we
have put together an interdisciplinary team of liver transplant surgeons, statisticians and machine-
learning experts who have worked together during the past year to build the environment that will
sustain the proposed project. Leveraging the robust statistical power derived from the aggregation
of data from thousands of perfused liver transplants worldwide, our ultimate objective is to
increase liver availability, mitigate complications, enhance patient outcomes, and provide
personalized clinical decision support for physicians caring for liver transplant patients. This
proposal holds the promise to fundamentally reshape the landscape of liver transplantation,
ushering in advancements that stand to significantly enhance the lives of thousands of individuals
awaiting liver transplants.

Public health relevance
Liver patients central would using advanced enhancing transplantation is a critical life-saving surgical procedure that offers survival hope to suffering from end-stage liver disease. Organ preservation by a machine has become a component of organ transplantation globally, allowing the usage of high-risk l ivers that be discarded otherwise. We aim to create an international cohort of perfused l iver cases a customized data-collection platform to improve preservation procedures and apply artificial intelligence methods to predict liver and patient outcomes, ultimately the lives of thousands of future liver transplant candidates.